Gene Transfer Core, NIDCR-DIR

In FY21, Gene Transfer Core successfully provided following services: Pronuclear injection service: 11 transgenic constructs were injected to generate 27 transgenic lines. CRISPR-based gene editing knockout service: The average efficiency for generating KO and KI mice for CRISPR-based constructs was 74% and 22%, respectively. A total of 27 transgenic mouse lines were generated by this service. Cryopreservation and IVF services: Sperm from 36 mouse models were cryopreserved for 13 investigators. Sperm from all mouse models were stored in two separate buildings. 12 sperm straws were thawed for 19 IVF sessions. 5 mouse models were successfully re-established per investigators request by the sperm cryopreservation service. Genotyping service: 90 tail biopsies were purified and used for genotyping by PCR analysis for 2 investigators. Gene Transfer Cores (GTC) services were interrupted during the first 4 months of the fiscal year due to COVID-19 concerns.